Einstein/Rwanda/DRC Consortium for Research in HIV/HPV Malignancies

ABSTRACT
In this U54, we propose to establish an HPV/HIV-Associated Malignancy Research Center
(HAMRC) as a partnership of institutions and investigators in Rwanda, the Democratic Republic
of Congo (DRC) and the United States (US), with an integrated, trans-disciplinary focus on
HIV/HPV-associated malignancies. The HAMRC is planned to have a coordinated and
integrated program of research and capacity-building (Developmental Core) in HPV-related
cancers in PLWH. The aim of the Developmental Core is to develop a cadre of junior and mid-
level researchers who will utilize the resources developed by the Center to catalyze research in
HPV/HIV-associated malignancies in Rwanda and the Democratic Republic of Congo (DRC).
This development of junior and mid-level researchers will be done through an apprenticeship
model in which they are paired with an experienced investigator in the development and
execution of a research protocol or a pilot project. Mentoring will be individually tailored for each
trainee, building on his or her prior training, research experience, interests and research
projects. In addition, a peer-reviewed pilot grants program will be utilized to stimulate
development of research projects specifically in HPV/HIV associated cancers. The
Developmental Core will be led by three African investigators who are all independently funded
researchers, thus, providing the ESIs with role models who have navigated challenges similar to
their own and strong examples to follow/learn from. In addition to the Core Directors, a team of
mentors will work with the trainees in the major research projects and potential pilot projects

Public health relevance
Project Title: Developmental Core of the Rwanda/DRC/Einstein HPV/HIV-Associated Malignancies Research Center (HHAMRC) The Developmental Core of the HHAMRC aims to develop a cadre of junior and mid-level researchers who will utilize the resources developed by the Center to catalyze research in HPV/HIV-associated malignancies in Rwanda and the Democratic Republic of Congo (DRC). The specific aims of the Developmental core are consistent with the goals of the center, and will have a significant impact on public health by building capacity of local researchers and mentoring them to become independent investigators and subsequently serve a leaders of the Center in the future. The Developmental Core will be led by African investigators who are all independently funded researchers, thus, providing the ESIs with role models who have navigated challenges similar to their own and strong examples to follow/learn from.